DATA COLLECTION AND DATA MANAGEMENT CORE

The Experience Corps Trial is a program project to evaluate the potential benefits to older adults and to the[unreadable] Baltimore City schools in which they volunteer, through a model of generativity in an aging society. Projects[unreadable] within the P01 will draw data from two related, randomized controlled trials - one randomizing older adults to[unreadable] participate in the Experience Corps (EC) program or to a control condition (involving referral for low intensity[unreadable] volunteer activity), the other randomizing schools to receive the EC program or not. Projects 1, 3, and 4 will[unreadable] use data from the randomized trial of older adults to evaluate hypothesized benefits to physical and cognitive[unreadable] functioning (Projects 1 and 3), as well as social and psychological functioning (Project 4). Project 2 will focus[unreadable] on school outcomes, while Project 5 focuses more broadly on evaluating program cost-effectiveness from a[unreadable] societal perspective. The Data Collection and Data Management Core will serve the needs of all five[unreadable] projects. Our intention is to promote coordinated, efficient collection of high-quality data for analysis. Major[unreadable] specific aims are to: 1) Coordinate data collection needs and design instruments that allow efficient and[unreadable] accurate collection of data; 2) Collect data for all program projects and perform data entry; 3) Manage IRB[unreadable] documentation and prepare the protocol, consent, and manual of procedures; 4) Create, provide[unreadable] technological support for, and perform quality control on a program-wide database system; 5) Obtain[unreadable] electronic school and program records; 6) Extract data sets for analysis and create HIPAA-compliant de-identified[unreadable] files for data sharing.